MRE elastography-based detection of impaired skull-brain decoupling after repetitive subconcussive sports impact

PROJECT SUMMARY/ ABSTRACT
Repetitive subconcussive head impacts (RHI) in contact sports are gaining attention, with prolonged exposure
linked to chronic traumatic encephalopathy and cognitive decline. Since RHI is often asymptomatic in the early
stages, there is an unmet need for early detection of RHI-induced impairments. In our previous grant cycle, we
focused on the function of connected anatomic interfaces, particularly the skull-brain (SB) interface (which has
evolved to isolate the brain from impact) and its early impairments due to RHI. We developed noninvasive harmonic
MR elastography (MRE)-based imaging markers to quantify SB mechanical decoupling, providing the first evidence
of early SB impairment in individuals with a history of asymptomatic RHI. We hypothesize that RHI exposure alters
the viscoelastic properties of the pia-arachnoid complex through repeated injury and healing. This impairment
increased with longer RHI exposure and decreased with longer intervals after exposure, suggesting individual
variability in the progression and repair of SB impairments. Other research also indicates that brain injury severity
varies significantly due to increased vulnerability from prior RHI exposure or inherent factors. These findings
highlight the need for further research into individual SB mechanical vulnerabilities (SBMV) and the longitudinal
effects of RHI, which is the focus of this renewal grant.
While harmonic MRE metrics developed in the prior grant cycle can assess SB decoupling at equilibrium and track
longitudinal changes from RHI, they may be less suitable for evaluating pre-existing individual SBMVs. The risk of
SB interface impairments or injury is hypothesized to be linked to spatial and temporal variations in SB interface
responses to real-life transient impacts, like existing research on brain injury risk predictions. However, as illustrated
in our preliminary data, harmonic MRE, which focuses on equilibrium vibration states, fails to detect regional
variations in cortical responses, which are revealed by transient MRE. Advancing from harmonic to transient MRE
is thus crucial for identifying SBMV, as transient MRE provides critical in vivo measures of high-risk SB interface
areas under low impact levels, with these regions likely remaining at risk or worsening under higher impacts,
presumably linking to SB decoupling variability in RHI outcomes.
In this renewal, Aim 1 addresses the technical challenge of implementing and validating a new transient MRE
method to efficiently characterize impulse responses. In Aim 2, we will build individualized SBMV maps and study
age/sex effects. In Aim 3, we will integrate harmonic and transient MRE in a longitudinal sports study, with two
goals: 1) detect post-season equilibrium SB decoupling changes, and 2) link the likelihood of these changes to pre-
season SBMV. Our hypotheses are: 1) post-impact mechanical alterations occur at the SB interface, and 2) these
alterations are related to pre-existing SBMV. We will also correlate MRE metrics with diffusion and cognitive
function for outcome predictions. Ultimately, this project aims to develop an imaging approach to identify individuals
at high risk for SB decoupling impairment from RHI, enabling targeted mitigation and recovery monitoring.

Public health relevance
PROJECT NARRATIVE Athletes in contact sports face not only the risk of concussions but also the lesser-understood yet adverse effects of repetitive subconcussive head impacts (RHI). We will develop a novel imaging technique based on magnetic resonance elastography (MRE) to longitudinally assess how RHI affects skull-brain mechanical decoupling before and after a sports season and evaluate how these changes correlate with the pre-existing mechanical vulnerabilities. The successful completion of this project will provide innovative methods and unique in vivo datasets for studying head biomechanics under low-amplitude, simulated real-impact conditions, detailed knowledge of brain vulnerabilities (including age/sex differences), and correlations with clinical outcomes to enhance understanding of RHI injury mechanisms, and a new imaging strategy for identifying high-risk individuals, facilitating the transition from expert judgment to evidence-based care in RHI-risk assessment.